Type 2 Diabetes: Understanding its Early Drivers and the Road to Therapeutics

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Type 2 Diabetes: Understanding its Early
Drivers and the Road to Therapeutics, organized by Drs. Christopher Rhodes, Lora Heisler, and Martin Myers.
The conference will be held in Palm Springs, CA from May 1 - 4, 2023.
Early detection and consequential intervention are key to good treatment outcomes and avoidance of
complications for most diseases. Arguably, this may not be the case for Type-2 diabetes (T2D) where
measures of elevated glucose and HbA1C, historically related to a predicted onset of retinopathy, occur too
late in the pathogenesis of the disease. This makes the need for improved markers of T2D necessary to
better diagnose and treat this prevalent disease at early stages. With the advent of precision medicine, now is
the time to re-examine the pathogenesis of type 2 (pre)diabetes at the molecular level. However, questions
the field remain, such as: 1. Which subsets of T2D define the rate of progression to certain diabetes
complications; 2. Can early molecular drivers of the disease be better identified; 3. What factors contribute to
dysfunctional inter-organ communication and altered metabolic homeostasis; 4. Does pancreatic ß-cell failure
really define the disease; and 5. If detected early enough, can we envision ways to reverse, or even prevent
T2D? The silver lining is that with several commonly used T2D therapies coming off patent soon, this may just
be conceivable. Nonetheless, there also remains a need for more effective therapeutic approaches, not just
for T2D, but also for its comorbidities. Therefore, this Keystone Symposia conference will examine the current
knowledge of T2D pathogenesis and the therapeutic landscape with a vision towards earlier diagnosis, as well
as, towards more effective and tailored T2D treatment regime(s) that could also prevent (or significantly delay)
the pathway to complications and comorbidities.

Public health relevance
PROJECT NARRATIVE Type 2 Diabetes (T2D) and obesity are metabolic diseases that show no signs of abating, and, as such, create a real need to evaluate how to better diagnose and treat the disease, as early as possible, in order to delay or even prevent life-threatening complications. This Keystone Symposia conference is designed to stimulate collaborations among participants by providing a setting conducive to focused, intense discussion between scientists with broad research interests at the crossroads of T2D and obesity. This will also include engaging with industrial partners interested in developing therapeutics for diabetes, obesity and the complications associated with these diseases in order to help improve patient treatments and outcomes.